Computational Studies of the Molecular Basis of Natural and Acquired Resistance to Extremes in Microbes

PROJECT SUMMARY
Our long-term goal is to understand how microbes are able to withstand remarkable extremes of
temperature, pressure, and chemical composition (P-T-X), by determining how the macromolecular
structures comprising the microbes are preserved. Our focus is on the effects of high pressure, which are
much less understood than those of temperature. Since high-pressure methods are increasingly being used
for food preservation, understanding the effects of pressure is important for human health and welfare.
Disturbingly, some mesophilic microbes appear to able to withstand ~10 kbar pressures, while piezophilic
(pressure-loving) microbes have been found at maximum pressures of ~1.1 kbar. Determining what
pressures will disrupt structures of proteins in cell-like conditions will help to define the limiting pressures
that microbes can grow at.
Our goal for the proposed work is to understand the interplay of P-T effects on proteins by
examining enzymes from psychrophiles (cold-loving) and thermophiles (hot-loving) that are also piezophilic
at different P-T. Based on our previous work on a piezophilic psychrophile enzyme, microbes may be mainly
adapted for temperature rather than high pressure and enzymes from psychrophiles appear much more
fragile than those from thermophiles. The proposed studies will expand the range of growth temperatures of
the source organisms to piezophilic thermophile enzymes. They will also address the effects of piezolytes,
which are osmolytes that protect against pressure effects, on proteins. Our approach uses molecular
dynamics computer simulations and biophysical experiments.
Our specific aims are to:
Aim 1. Understand piezophilicity in other psychrophile enzymes.
Aim 2. Understand piezophilicity in thermophile enzymes.
Aim 3. Understand how piezolytes change pressure effects on proteins.

Public health relevance
RELEVANCE Computational studies of proteins under pressure will provide a fundamental, molecular understanding of protective mechanisms used by microbes to protect their proteins against high pressure. These mechanisms include genetic modifications of proteins for stability as well as changes in the intracellular milieu. Understanding the nature of these mechanisms is crucial in designing protocols for food preservation that involve high pressure.